Role of KCTD proteins in striatal signaling

Project Summary
Alterations in striatal cAMP signal transduction contribute to the progression of movement disorders, whose
increasing prevalence present a significant public health concern. Therapeutic options for movement disorders
are limited in part by a deficient understanding of the molecular control of cAMP signaling in striatal neurons.
Although tremendous progress has been made in unraveling the cAMP pathway, complexity of cAMP
regulation in the striatum coupled with the large number of players with pivotal roles not yet fully elucidated has
slowed progress towards more effective care strategies. To overcome this barrier, our long-term goal is to
better understand the mechanisms and principles that control striatal cAMP signaling. The proposed work
focuses on the role of Potassium Channel Tetramerization (KCTD) proteins in modulation of striatal signaling
through G protein coupled receptors (GPCRs). KCTD proteins were recently implicated in GPCR signaling
both directly by engaging with G proteins and indirectly by influencing zinc influx through zinc transporters.
However, the details of KCTD regulation of G protein signaling and consequences of zinc on striatal signaling
are only beginning to emerge. The goal of this proposal is elucidation of the KCTD-Zinc-cAMP signaling axis in
the native neuronal environment. In Aim 1, we will use biochemical assays to study negative feedback
pressure that dynamically adjusts KCTD expression in the striatum followed by optical assays to study how
KCTD regulate interaction of G proteins with effectors. Aim 2 will utilize biochemical assays and optical
sensors in live neurons to delineate precise mechanistic details of KCTD and zinc on striatal cAMP signaling.
In Aim 3, we will address how KCTDs shape native physiological signal interrogation by optically stimulating
neuromodulatory release with concurrent 2-photon imaging of signal integration across intact circuits in
genetically defined striatal neurons expressing optical sensors. In total, the proposed research is expected to
be significant in that it will provide essential mechanistic and physiological insight into the KCTD-Zinc-cAMP
impact on signaling processes critical for motor physiology.

Public health relevance
Project Narrative Movement disorders are a collection of neurological disorders that lead to abnormal motor control, which results in a considerable public health concern. The studies in this proposal will investigate neuronal signaling processes that play an essential role in motor function. A better understanding of the mechanisms that modulate information transfer between neurons is expected to have practical implications for targeted therapy in movement disorder patients.